MULTIPLE COURSES OF ORTHOCLONE OKTCDR4A IN RHEUMATOID ARTHRITIS

This multiple intravenous infusion study was undertaken to assess the safety, tolerability, clinical activity, pharmacokinetics, and immunologic activity of multiple courses of Orthoclone OKTcdr4a. A total of 5 patients were enrolled and the study was completed September 11, 1995. There were no unexpected events or side effects. Preliminary data has been collected and analysis is proceeding.